AOU WI Area of Interest 1: Community, Participant and Provider Engagement, Enrollment...

1. ABSTRACT
The All of Us Research Program (AoURP) has experienced dramatic change over the last five
years. To list just a few of the many examples: AoURP conducted multiple retention eligible
campaigns (e.g., mental health campaign), began distributing genetic results to participants,
initiated the first ancillary study (Nutrition for Precision Health), and made available the Research
Workbench to scientists. Throughout the many changes that have occurred over the years, the
most challenging was the SARS-Cov-2 pandemic which disrupted every facet of society and
impacted how AoURP's partnering institutions functioned. But with change comes opportunity,
and opportunity is possible for organizations that are highly adaptable and innovative. This
includes the All of Us Wisconsin Consortium (AoU-WI).
AoU-WI was one of the last RMCs to join the national program. As time progressed, AoUWI
matured, strengthened close collaborations across WI and nation, and developed diverse
strategies in engagement, enrollment, and retention. The diversity at all levels of AoU-WI is
something we are most proud of and has allowed our program to flourish in the ever-changing
AoURP. To maintain AoU-WI's momentum, we will leverage lessons learned from the last five
years. AoU-WI will constantly reassess, modify, and diversify its strategies to ensure AoURP is
available to all. Continued diversity in our program will be essential as AoURP persistently
changes over the next five years.
In this application, we will describe how AoU-WI will not only maintain successful activities
that has allowed our program to be leaders in engagement, enrollment, and retention, but how we
intend to innovate. We will conduct outreach and engagement activities to promote the enrollment
of communities who are historically underrepresented in biomedical research (Aim 1). AoU-WI
will also engage, enroll, and retain participants who reflect the rich diversity of the US (Aim 2).
This will be done with both adults and pediatrics (Aim3) while ensuring participants have access
to technology for study activities (Aim 4). Lastly, AoU-WI will engage and collaborate with health
care providers serving communities that are historically underrepresented in biomedical research
to facilitate enrollment and retention (Aim5). We will do this by expanding the AoU-WI
consortium to include Advocate Aurora Health, the ninth largest not-for-profit integrated
healthcare system in the U.S.
By successfully achieving these aims, AoU-WI ensures our continuous contribution to the
mission of "accelerating health research and medical breakthroughs, enabling individualized
prevention, treatment, and care for all of us."

Public health relevance
Data collected as part of AoURP is not about one single disease or even a class of diseases; it is about all diseases that can impact the health and wellbeing of all Americans. This resource will foster academic freedom, transparency, and be a trusted dataset for the public and scientists alike.